CSHL Mechanisms of Aging Conference (2024 - 2028)

Abstract
MECHANISMS OF AGING
September 24 – 28, 2024 / fall 2026 / fall 2028
The first meeting in the proposed series on the Mechanisms of Aging is to be held in fall 2024 at Cold Spring
Harbor Laboratory. Since its inception 22 years ago, this conference has arguably become the leading venue for
presentation of the latest progress in aging research, which is a rapidly expanding and fast-moving research
field. This conference has experienced a 27% growth of total participants since 2012, with attendees surpassing
300 in 2018, while the virtual format attracted almost 600 in 2020 and the post-pandemic hybrid format attracted
over 325 in-person and over 200 virtual attendees in 2022. National and international interest continues to
increase, such that over the next three iterations of the meeting, the expectation is that each meeting will bring
together 400-500 scientists from around the world working on different aspects of the molecular genetics of
aging, with an anticipated additional virtual audience of several hundred.
The meeting will provide an in-depth forum for presentation of new findings in different areas of aging research.
The 2024 meeting will include the following 8 platform sessions: Stress Response, Metabolism, Autophagy,
Inflammaging, Quantitative Biomarkers of Aging, Reproductive Aging, Cell Non-Autonomous Regulation of
Aging, and Stem Cells/Reprogramming. Two poster sessions will also be included.
The oral sessions will be chaired by two leading scientists in the field and will feature eight short talks selected
from openly submitted abstracts, which will be evaluated three months before the meeting. This is exceptional
in that it promotes the development of new ideas by facilitating the presentation of late-breaking findings.
Moreover, the meeting routinely accommodates a large percentage of presentations by students and postdocs,
thereby fostering the next generation of young scientists and helping them promote their careers in aging
research. These young researchers will also benefit from organized mentoring and career development activities,
such as small-group lunches with session chairs and career dinners with senior leaders.

Public health relevance
This biennial conference series on the Mechanisms of Aging at the Cold Spring Harbor Laboratory is designed to be an interdisciplinary forum that accelerates research into the biological basis of aging, which will improve treatment for age-associated diseases and reveal mechanisms of the aging process itself. The conference is unique in the aging research field because it features selected talks from influential invited speakers combined with a large number of short talks chosen by the organizers from openly submitted abstracts, which are submitted three months before the meeting. This format provides ample opportunity for presentation of cutting-edge discoveries and for broad and diverse representation of junior scientists. The research program is augmented by mentoring and career development events that target graduate students and post-doctoral researchers.